The Signal Transduction in the Immune System Conference

PROJECT SUMMARY/ABSTRACT
This application seeks partial funding for a FASEB Summer Research Conference (SRC) on "Signal
Transduction in the Immune System", to be held June 11-15, 2023 in Palm Springs, CA. The overall goal of
this conference is to provide a comprehensive survey of recent advances regarding the signaling mechanisms
involved in the response of immune cells in both health and disease. The meeting in 2023 will be the 11th
occurrence of this FASEB conference. It was originally scheduled in June 2021 but has been postponed
multiple times due to the COVID pandemic. This particular FASEB conference has historically attracted
widespread interest from both academia and industry because of the outstanding speaker rosters, the cutting
edge nature of the work presented, and the relevance of many presentations to immunologic diseases.
Additionally, since most mainstream immunology meetings do not provide an in-depth focus on signal
transduction mechanisms, this dedicated FASEB conference has attracted leaders in immune signal
transduction worldwide, as well as new investigators and students. Topics for the 2023 conference include
innate immune cell sensing, leukocyte adhesion and migration, lymphocyte signaling, signaling and effector
function, and immune signaling in health and disease. We anticipate that these topics will appeal to a broad
swath of researchers in both basic and translational areas. Although the conference has a backbone of regular
attendees and speakers, we have ensured that new ideas and research areas will be addressed in 2021 by
featuring 12 new invited speakers (out of 35). We have also prioritized representation of women (45% of
speakers) and underrepresented minorities (among the invited speakers. In addition, all sessions will have
space for short talks (which will be selected from abstracts). New to the 2023 conference are two Lightning
Sessions with a total of twenty 1-minute talks from trainees to highlight their poster session presentations
(selected from abstracts). Priority for short talks will be given to new investigators, post-doctoral fellows, and
students from groups in which PIs are not presenting. This will ensure a diversity of topics and speakers at the
meeting. The overall objectives of the meeting are: 1) To provide a critical and intensive overview of the recent
advances in signaling pathways controlling the innate and adaptive immune systems; 2) To bring together a
diverse group of scientists across all career stages (including postdoctoral fellows and students) of both
genders, in a stimulating and supportive atmosphere involving formal presentations and informal discussions;
3) To provide opportunities for trainees and early-career scientists to present their research to a broader
scientific community; and 4) To advance research on molecular mechanisms in the immune system by broadly
disseminating information and recent breakthroughs. We anticipate that this conference will build upon the
success of past conferences in influencing the direction of signaling research in the immune system.

Public health relevance
PROJECT NARRATIVE The major goal of this conference is to showcase recent advances in our understanding of signal transduction mechanisms that control immune responses in both health and disease. This conference will contribute to the rapid advancement of research on the immune system by providing a forum for a diverse community of scientists across all career stages to share and discuss their research. In addition, the conference will catalyze new ideas and the use of interdisciplinary approaches for the development of novel therapeutics to treat inflammatory and autoimmune disorders, as well as cancer and immunodeficiency.